NGS based metagenomic screening of ocular infections

Project Summary/Abstract:
The project objective is to develop an organism-agnostic deep sequencing-based diagnosis of ocular infectious
disease from microliter-sized biopsies in less than 24 hours and for less than $1000. Current diagnostic
approach relies on bacterial and fungal cultures that are time-consuming (~2-3 days) and often leads to the
overuse of broad-spectrum antibiotics. In Phase I, we successfully developed and validated the EYE-Path™
system, demonstrating an integrated Scalable Metagenomics Alignment Research Tool (SMART) with an
automated DNA extraction system for sample preparation. This system achieved a low limit of detection (104
cells/mL) and a turnaround time of <3 hours for bacterial infections.
In Phase II, we plan to optimize the adaptive sequencing software for the SMART Adapt algorithm, validate the
system in a multi-site clinical study (University of California, Los Angeles and University of Washington) in
patients with corneal ulcer and suspected endophthalmitis, validate the system as a CLIA ready test and
initiate a pre-submission meeting with the FDA to determine the appropriate regulatory strategy for eye-PATH
to be considered as a CLIA waived in vitro-diagnostic device. The success completion of this project could
significantly impact ocular infection diagnosis and treatment planning, with broader applications in point-of-care
devices and non-ophthalmic diagnostics, helping to combat antimicrobial resistance.

Public health relevance
Project Narrative: In ability to accurately identify pathogen leads to proliferation of antibiotic resistant microbial strains, persistence of infections and ultimately treatment failures. For instance, over 15% of enterococcal isolates are now vancomycin resistant (VRE); an organism known to cause endophthalmitis, a vision-threatening infection. To address this, we have integrated Scalable Metagenomics Alignment Research Tool (SMART) adaptive sequencing algorithm developed by University of Washington (UW) and licensed to ChromoLogic (CL), with a host-DNA depleting sample preparation and library preparation protocols that enable ocular sample-to pathogen identification (EYE-Path™) in less than 3 hours. Current bacterial culture can take up to 48 hours and often requires specialized skills and expertise. EYE-Path™ offers real-time metagenomics platform for the detection of low abundant microbial DNA in the setting of high host background. ChromoLogic aims to optimize high-throughput operations, establish the system software architecture, and achieve CLIA review as a Laboratory Developed Test (LDT). The goal is to offer it as a CLIA waived in-vitro diagnostic device, initially as a "Software as a Service" product and eventually as an FDA-cleared pathogen-agnostic IVD. EYE-Path™ holds the potential provide a rapid, comprehensive pathogen-agnostic diagnosis that is cost-effective.